CB1-mediated signaling in developmental ethanol effects

Project Summary
During pregnancy, alcohol abuse produces persistent changes in the fetal brain, causing behavioral
impairments throughout life. These conditions are defined as fetal alcohol spectrum disorder (FASD). Most
concerningly, regular binge drinking during pregnancy causes cognitive and socio-behavioral deficits in offspring.
However, the molecular mechanisms underlying persistent alcohol-induced neurobehavioral impairments are not
fully understood. Our previous studies demonstrated that alcohol exposure results in CB1 signaling defects in
neonatal mice (P7) that cause neurodegeneration and behavioral deficits in adults. Other data also implicate CB1
in the teratogenic effects of alcohol. However, whether synaptic and behavioral deficits are due to alcohol-induced
changes in CB1 and its signaling events within the adult hippocampus (HP) and prefrontal cortical (PFC) regions
remains largely unknown. CB1s are mainly expressed in glutamatergic and GABAergic neurons. They can elicit
cell-type-specific signaling depending on where they are activated and contribute to neuronal and behavior
outcomes. CB1 activity also regulates gene expression via epigenetics; however, the mechanisms are unknown.
Our recent pilot findings suggested that human third-trimester-equivalent alcohol exposure in neonatal mice caused
persistent cognitive and social behavior deficits. These behavioral changes were accompanied by increased CB1
expression, histone methylation, and reduced expression of genes essential for synaptic structure and function in
specific neuronal types. These findings suggest that alcohol alters the transcriptional control of gene expression
and synaptic function in a given cell type in the PFC and HP. This proposal will test the hypothesis that a mechanism
underlying synaptic dysfunction in the PFC and HP contributing to behavioral deficits is enhanced CB1 activity and
histone methylation by postnatal alcohol leading to aberrant synaptic gene expression. This proposal will test these
hypotheses in PFC and HP using cell-type-specific (Cre or CreERT2) RiboTag (TRAP) technology to study CB1 and
histone methylation events altered by postnatal alcohol exposure (PAE). We will pay special attention to evidence
of aberrant regulation of histone methylation responsive genes related to spine and synaptic vesicle function.
Additionally, we will investigate the role of histone methylation on synaptic structure and function by conditional
deletion (cKO) of the CB1 gene or a gene encoding a histone-methylation-related enzyme (FloxP lines) in the
specific neuronal type (CreERT2) in the adult PFC and HP. Finally, we will mechanistically test the effects of
modulating histone methylation levels using cKO of CB1 or histone methylation enzyme function in specific neuronal
types to rescue adult cognitive and social behaviors. These studies will use sex-dependent models to perform a
combined epigenetic, synaptic, and behavioral analysis of the response to PAE. Our goals in this proposal are to
identify the mechanisms underlying the long-lasting changes in CB1 and histone-methylation-related transcriptional
and synaptic changes in the PFC and HP and determine their contributions to the persistent cognitive and socio-
behavioral deficits resulting from PAE. The findings will elucidate pathways and provide possible novel targets for
therapeutic intervention in PAE-related neurological disease.

Public health relevance
Project Narrative: Fetal alcohol spectrum disorder (FASD) is a significant non-genetic neurodevelopmental disability in which affected individuals display cognitive and social abnormalities. The studies herein examine the cell-type-specific cannabinoid receptor-epigenetic mechanism by which postnatal ethanol exposure causes cognitive and social- behavioral defects. The findings will address our knowledge gap in understanding cell-type-specific CB1 mediated epigenetic mechanisms and inform us why the developmental brain is, therefore, vulnerable to alcohol's damaging effects. Moreover, the findings of the proposed studies may be used by health care professionals in counseling women on the potential adverse impacts of alcohol abuse during pregnancy.